Optimization and Normalization Studies for CSF as a Biomarker

DESCRIPTION (provided by applicant): Traumatic brain injury, both from direct trauma to the brain and as a sequela of ischemic or hemorrhagic infarction are associated with a significant rate of morbidity, mortality and cost to both patients and the healthcare system. Hemorrhagic infarcts (such as aneurysmal subarachnoid hemorrhage and intraventricular hemorrhage) are rare but devastating complications of arterial rupture. Despite significant effort, there has been little improvement in the outcomes of patients with aneurysmal subarachnoid hemorrhage (aSAH) or intraventricular hemorrhage (IVH). Given the predictable temporal course of these brain injuries, they are ideal candidates for biomarker identification. A biomarker for detection o 'at risk' patients and a prognostic indicator of delayed neurological deficit would vastly improve current treatments and increase our understanding of underlying pathological events. This information would immediately lead to the implementation of new therapeutic strategies. Research over the last several years has identified extracellular RNAs (exRNA) as a potential source of biomarkers. New technology, such as next generation sequencing (NGS), has made it possible to sensitively and quantitatively assay small amounts of RNA contained in clinically attainable volumes of biofluids such as CSF and blood plasma. In the first two years of this grant, we propose to sequene the exRNA (miRNA and total RNA) from both the CSF and plasma of patients who present with aSAH and the plasma and CSF from premature infants born with IVH. aSAH samples were collected daily~ the volume of sample available will allow us not only to sequence the total RNA including miRNAs, but will permit us to explore unique enrichment strategies in years 3-5 of this grant~ we will examine specific RNAs associated with microvesicles in both CSF and plasma. We have both the daily clinical evaluations of these patients as well as their outcomes (25 subjects in all). We will use these samples to identiy RNA markers that predict onset of vasospasm and the severity of delayed neurological deficits. We also have CSF and plasma samples collected every other day from premature infants with grade III-IV IVH that had reservoirs put in place to evacuate blood and excess CSF. We also have the clinical outcomes from the infants, whether or not they developed hydrocephalus, the need for a permanent shunt, and an 18 month assessment of developmental delays or disabilities. In years 3-5, we will continue to collect samples in collaboration with both of our clinical partners. At that time, we will switch from our discovery platform, the Illumina HiSeq 2000 that has high depth of sequencing coverage, to the Illumina MiSeq for validation. Once the discovery phase is complete and potential biomarkers identified, validation can be carried out on the MiSeq's faster fluidics, imaging, and shortened run times without changing chemistries between the discovery and validation phases.

Public health relevance
PUBLIC HEALTH RELEVANCE: The purpose of this research is to identify a biomarker to predict complications of brain injury, allowing us to decrease the severity and number of poor outcomes. The predictable temporal onset of brain injuries associated with intraventricular hemorrhage and aneurysmal subarachnoid hemorrhage make them highly amenable to the identification of a biomarker that can be used to alter and monitor treatment strategies. __SpecificAimsTextDelimiter__ Specific Aims - Traumatic brain injury as sequela of ischemic or hemorrhagic events, are associated with significant rates of morbidity and mortality and high costs to our health-care system. Intracranial bleeds are devastating events that afflict both pediatric and adult populations. Intraventricular hemorrhage (IVH), in premature infants, and aneurysmal subarachnoid hemorrhage (aSAH), in adults, are often the cause of permanent neurological complications. Despite their etiological differences, both of these brain injuries occur within well-defined time frames, giving us the opportunity to assay extracellular RNA (exRNA) to identify pathways of secondary injury, identify biomarkers that may predict outcome, and help tailor strategies for patient treatment. The identification of predictive biomarkers would significantly change current standards of care for these types of injuries. We have serial collections of cerebrospinal fluid (CSF) and plasma samples from patients with hemorrhagic infarcts (both aSAH and IVH) for biomarker discovery. We will use the Illumina HiSeq 2000 to exhaustively sequence the extracellular miRNA (ex-miRNA) and the whole transcriptome exRNA from the samples and identify differentially expressed exRNAs (Aims 1 & 2). We will use this data to do high-level analysis to classify exRNA markers predictive of neurological outcomes (Aim 3). The volume of biofluids that can be obtained from subjects with such brain injuries is substantial, giving us the opportunity to examine innovative ways to increase accurate detection of our biomarker in the validation phase. We will employ enrichment techniques to increase our biomarker sensitivity and specificity (Aims 3 & 4). During the validation period, we will identify biomarker candidates, collect additional samples from aSAH and IVH subjects, and use faster assay platforms (MiSeq and qRT-PCR) to quantify our exRNA marker. We have already begun collaboration on these projects, and have some preliminary data. While these data are preliminary, they are a good indication that we can use changes in exRNA that result from brain injury as markers for disease severity and outcome. Aim 1 - Sequence exRNAs from subjects with aSAH and grade III-IV IVH: small RNA (miRNAs) and whole transcriptome RNA. A) Sequence exRNAs from the CSF and plasma of patients with aSAH. We prospectively enrolled 25 patients who presented to Barrow Neurological Institute (BNI) after aSAH and required insertion of an external ventricular drain. Plasma and cerebral spinal fluid (CSF) samples were collected on days 1-10 and 14 post- hemorrhage~ data collection included daily neurological exams and medical records. We sequenced the small RNA fraction from approximately half of the samples, preliminary data strongly implies that there are miRNAs differentially expressed between patients that exhibit vasospasm and those that are asymptomatic, and that we will be able to detect a miRNA marker for injury and vasospasm. 25 subject samples, plasma and CSF, 11 days of sample collection, 550 samples will be sequenced for ex-miRNA. We will sequence days 3-7 post- hemorrhage (250 samples) for whole transcriptome RNA. Years 1 & 2. B) Sequence exRNA profiles from the CSF and plasma of premature infants with grade III-IV IVH. We collected CSF and plasma samples from 15 premature infants with grade III-IV Intraventricular Hemorrhage (IVH) that required placement of a reservoir to evacuate CSF. Samples of CSF and plasma were collected every other day for two weeks (total 210 samples). We will sequence both the whole transcriptome as well as the miRNA fractions. We will correlate the exRNA markers identified in these samples with the development of post- hemorrhagic hydrocephalus, the requirement for a ventriculoperitoneal shunt, and neurodevelopmental delay. Babies will have follow up visits to assess neurodevelopmental outcome. Years 1 & 2. Aim 2 - Analysis of the sequencing results and validation of differentially expressed exRNAs. All data will be processed through the appropriate sequence analysis pipeline~ sequence data will be trimmed, aligned, examined for appropriate coverage, normalization, variability, and removal of outliers. We will do analysis for differentially expressed exRNAs and validate them with a second assay, qRT-PCR. Years 1 & 2. Aim 3 - Continued sample collection, identification and validation of biomarker candidates. Once all the initial data are assembled, it will be analyzed and correlated with the clinical assessments collected on the subjects. We will use standard univariate statistical tests such as t-test and SAM for identifying differential expression of exRNAs, using multiple testing corrections. We will then employ more powerful multivariate analyses to identify multivariate biomarkers with acceptable performance predictions. Clinical collaborators will collect samples throughout years 1-5. These analyses, therefore, will be constantly revisited, reassessed and evaluated throughout years 3-5 as we collect additional samples, (25 aSAH subjects each year, total 75~ and 10 IVH each year, total 30) and continue to revise and strengthen our candidate biomarkers. Years 3 - 5. Aim 4. Innovative RNA isolation strategies and diagnostic platform testing. We need to identify a platform that can sensitively and accurately detect changes in the expression of the exRNA on a rapid time scale~ test enrichment strategies to amplify the exRNA signal. Continue to validate and improve the performance of the platform, enrichment approaches and biomarker candidates. Years 3 - 5.